Supplement for Kentucky BIRCWH Program: Training the Next Generation of Women's Health Scholars: Dr. Conner

Abstract
The BIRCWH program at the University of Kentucky (UK) has been extremely successful in creating
a research environment to prepare early career scientists with necessary skills to become
independent NIH-supported researchers dedicated to improving women’s health. This supplement will
continue the training of a 4th BIRCWH scholar, Dr. Laneshia Conner who is from an underrepresented
racial minority group, with the goal of developing research skills necessary to become an independent
researcher engaged in intervention development for older Black women in real world settings. HIV
remains a major public health issue, with adults aged 50 and older experiencing an increase in HIV
diagnoses over the past two decades, and, 82% of HIV infections transmitted through heterosexual
contact. Black women continue to be disproportionately impacted by HIV, making up less than 15% of
the female population yet accounting for half of new HIV infections in women in the U.S. Older Black
women are often overlooked when it comes to HIV prevention services, due to ageism and stigma
about high-risk behaviors among older adults, and lack of an empirical base about older Black
women. Dr. Conner will continue to acquire skills to launch her research program in three areas:
intervention development, developing sustainable community programs for older adults, and
expanding methodological skills for a future RCT research. The proposed project will develop a
culturally relevant Woman 2 Woman (W2W) intervention that has been adapted to address unique
gaps in HIV prevention that target older Black women and provide data on the feasibility and
acceptability of the intervention in addition to the measuring behavioral and knowledge outcomes.
Working with two low-income housing complexes for adults over the age of 50, older Black women
will be recruited to participate in a multisession, group-level behavioral intervention adapted to
address both physiological risk as well as low perception of risk. High unknown serostatus suggest
that HIV prevalence may be higher than reported among older adults. Implementation, assessment
procedures, and protocols will inform a subsequent full-scale randomized clinical trial. The objective
of this innovative project is to develop and test the feasibility, acceptability, usability, and preliminary
efficacy of Woman to Woman (W2W) using a mixed methods approach. Specific aims are: (1) Adapt
the group-level intervention (W2W) focused on reducing HIV risk and increasing decision making
skills in older Black women to include reproductive health histories in exploring the impact on sexual
decision making and risk behaviors, and (2) Conduct a pilot study of the revised W2W intervention in
two community sites to evaluate acceptability and feasibility.

Public health relevance
Project Narrative There are no known evidence-based interventions targeting the prevention of HIV transmission among older Black women in the U.S., which is a major public health concern as there is a growing aging Black American population living with HIV. The objective of this innovative project is to develop and test the feasibility, acceptability, usability, and preliminary efficacy of Woman to Woman (W2W), an HIV intervention for older Black women. The mentorship and training activities, combined with the implementation of the feasibility trial, within this BIRCWH supplement will provide the needed skills and data for the BIRCWH scholar, Dr. Laneshia Conner, to address comments for her competitive K01 to conduct a large scale randomized controlled trial to assess the impact of the W2W intervention in reducing HIV risk among older Black women.